ADAPTIVE COMPUTING AND BIOMEDICAL APPLICATIONS

A program in the Mathematica language was prepared for ALLFIT analysis making available a more generalized system of models. Due to problems with curve-fitting and retirement of the author of the program, this program was not made a production system. A package of Mathematica functions for manipulation of polynomials with multiple variables was completed, and a talk was given on it at the Mathematica Developers Conference held in April 1994. A manuscript describing this package was submitted for publication in the Mathematica Journal. Research in neural networks and preliminary investigations of the Boltzmann machine and the Gibbs sampler were discontinued due to the retirement of Dr. Hutchinson.